UMB IMSD

PROJECT SUMMARY
To address the lack of diversity in the science, technology, engineering, and math
(STEM) workforce, the UMB IMSD program aims to increase the participation of
underrepresented minorities (URs) in biomedical PhD programs, increase their retention
rates, and provide career development to prepare these students for a future career in
STEM. UR participation and retention in graduate school is hampered by multiple
factors. Institutional environment, the lack of a large cohort, and encountering racial
microaggressions are all contributing factors to UR attrition in PhD programs. Further, a
lack of strong mentoring connections is also a mitigating factor. To address these
issues, the UMB IMSD will provide programming to increase retention and better
prepare these students for their future careers. The program will provide workshops on
scientific writing and provide opportunities for students to hone their presentation skills.
Workshops on stress management, mindfulness, and dealing with microaggressions will
also be provided. To strengthen student-mentor relationships, faculty will be provided
workshops to educate them on the unique challenges that UR students face and open
discussions between faculty and students will be carried out. Trainees will be educated
on the various career tracks in the STEM field via a Diversity Seminar series. The IMSD
plans to recruit 10 students per year and trainees will be appointed for one year, their
first year of graduate school. This program will help students transition to successful
careers in the STEM workforce.

Public health relevance
PROJECT NARRATIVE It has been demonstrated that diverse groups lead to increased productivity in the workplace. In STEM fields, this diversity is lacking with limited participation of members from minority groups. The UMB IMSD program will focus on the recruitment, retention, and professional development of students from underrepresented groups to prepare them for careers in biomedical science.